A molecular and physical mechanism for growing and branching the intestinal villus

ABSTRACT
Villi are finger-like projection that line the lumen of the small intestine where they aid in nutrient uptake by
increasing the intestinal absorptive surface area. Villus atrophy causes major digestive complications and
nutrient malabsorption. Abnormalities in villi are found in many gastrointestinal maladies, such as inflammatory
bowel and celiac diseases, and are also side effects of radiation, chemotherapy, and infection. Degenerated villi
can sometimes fully reform, but persistent villus atrophy causes severe complications and patient suffering.
Thus, understanding the molecular and mechanical mechanisms underlying villus formation and repair are
essential to develop new therapies and for growing and regenerating intestinal tissue for human patients. Villi
emerge during development from an initially flat intestinal surface. We recently demonstrated that the forces
necessary and sufficient to pattern and fold the epithelium during the initiation of villus morphogenesis derive
from a population of Pdgfrahigh cells that differentiate at the interface of the epithelium and mesenchyme. These
cells form a motile monolayer that breaks up into compact aggregates that fold the overlying epithelium in a
Myosin-II, Hedgehog, MMP and integrin-dependent manner. We named this process “active mesenchymal
dewetting.” Following this critical symmetry-breaking event, however, villi must increase their length by at least
four-fold. This process coincides with the differentiation of the overlying epithelium into Wnt-responsive
proliferative domains in between villi, and non-proliferative domains overlying villi. Finally, villus initiation and
extension repeats itself at least four more time in a manner highly reminiscent of branching morphogenesis.
Guided by our findings in revealing the mechanism of villus initiation, we propose to test three hypotheses related
to the molecular and mechanical processes driving villus extension, villus branching, and epithelial zonation.
First, we hypothesize that forces driving villus extension derive from a transition of proliferative, dynamic and
narrow epithelial cells, to a non-proliferative, static, and wide morphology as they move into villus domains.
Second, we hypothesize that epithelial zonation derives from Pdgfrahigh clusters physically pushing the overlying
epithelium away from a critical source of Rspo2 and 3 in the deep mesenchyme. Third, we hypothesize that
repeated rounds of villus “branching” occur when the intervillus proliferative epithelium “pushes” into the
mesenchyme, causing it to thin, and exposing a population of Pdgfralow cells in the deep mesenchyme to the
surface where they come in contact with epithelial hedgehog and differentiate. We will test these hypotheses
using an innovative combination of live imaging, mouse genetics, computational modeling, and mechanical
perturbations. This project has major implications for our understanding of the developmental of the gut and for
tissue engineering because it will provide a new mechanistic blueprint for building villi incorporating both signals
and forces. These findings will also lay the groundwork for future studies of regeneration: the adult sub-epithelial
mesenchyme retains expression of many of these cell types and many are activated following injury.

Public health relevance
PROJECT NARRATIVE Intestinal villi are finger-like projections that are essential for nutrient absorption and become disrupted in inflammatory bowel diseases and following radiation, chemotherapy, and infection. The regenerative process of villi is often impaired, and persistent villus atrophy can cause significant clinical challenges. In this application, we will reveal the forces and molecules that act in the mammalian embryo to pattern and shape villi, which will aid in the design of new strategies to promote villus regeneration in vivo and to build replacement tissue ex vivo.